Interdisciplinary Research:Antimicrobial Resistance(RMI)

[unreadable] DESCRIPTION (provided by applicant): [unreadable] While much progress has been made to control preventable infectious diseases, infections remain a major cause of morbidity and mortality. Many of the traditional treatments for common infections are no longer effective because of the fast-growing problem of antimicrobial resistance, first associated with hospitals but increasingly widespread in the community. Antibiotic resistance is now a global problem of major concern. The ultimate goal of this proposed Center for Interdisciplinary Research on Antimicrobial Resistance (CIRAR) is to develop strategies to implement and evaluate a long term collaborative program of interdisciplinary research on reducing antimicrobial resistance. The specific aims of the CIRAR are: (1) To plan, implement, and evaluate outcomes of a core program and curriculum to prepare medical researchers to conduct interdisciplinary research; (2) To develop the expertise of CIRAR investigators in interdisciplinary research; (3) To conduct and evaluate outcomes of interdisciplinary demonstration projects related to the prevention and control of antimicrobial resistance; (4) To implement dissemination and implementation strategies that maximize the sustainability and expansion of CIRAR's interdisciplinary research; and (5) To formalize plans for a sustainable Interdisciplinary Research Consortium for Antimicrobial Resistance. The first component of the Center is the development and implementation of formal training for conducting interdisciplinary research which will be incorporated into several ongoing programs within the institution and made available by internet. In Years 2 and 3 the interdisciplinary research curriculum will be further disseminated. The second CIRAR component is the development of interdisciplinary demonstration projects designed to rationalize antimicrobial use and reduce antimicrobial resistance. In the final year, plans for a sustainable Consortium on antimicrobial resistance will be formalized. [unreadable] [unreadable]